KIR-FAVORABLE HAPLOIDENTICAL TRANSPLANTATION IN CHILDREN

DESCRIPTION (provided by applicant): The most common indication for allogeneic hematopoietic stem cell transplantation (HCT) in children is high- risk acute leukemia, with equal distribution between acute myeloid leukemia (AML) and acute lymphoblastic leukemia (ALL). With advances in risk-classification, donor tissue typing, conditioning regimen, and transplant care, outcomes for transplant recipients have steadily improved over time. Thus, HCT is now a well-accepted therapy for children with myelodysplastic syndrome (MDS) and many subtypes of high-risk ALL and AML. A key question remains regarding the best approach to the 40-50% of children who do not have matched donors available. Encouraging data have been published recently using unrelated human leukocyte antigen (HLA) - mismatched umbilical cord blood (UCB) in both the adult and pediatric populations. Excellent outcomes were also observed with killer-cell immunoglobulin-like receptor (KIR)-mismatched HLA-haploidentical HCTs. However, no direct comparisons of these two stem cell sources have been performed in children. In this proposal, five participating institutions of the Pediatric Blood and Marrow Transplant Consortium (PBMTC) will examine the feasibility and outcome of HCTs in patients who will receive an HLA-mismatched graft because a matched donor is not available. Based on the availability of a KIR-favorable parental donor, the participant will be biologically assigned to receive an HCT from either a KIR-favorable haploidentical donor, or the best alternative donor (typically HLA-mismatched UCB). Specific Aim 1 will assess the disease-free survival at 1 year after transplantation and costs of a favorably KIR-mismatched haploidentical HCT in a multi-center setting. The primary hypothesis is that T- and B-cell-depleted, favorably KIR-mismatched, haploidentical HCT is feasible in a multicenter setting and will result in an 80% DFS at 1 year with acceptable standardized costs and outcomes comparing favorably with unrelated UCB HCTs in the 5 participating centers and in CIBMTR registry. Furthermore, recent data suggest that patients who received a donor graft containing the functionally stronger KIR2DL1 alleles with arginine at amino acid position 245 (KIR2DL1-R245) had better survival and a lower relapse rate than those who received a donor graft that contained only the functionally weaker KIR2DL1 allele with cysteine at the same position (KIR2DL1-C245). Therefore, in Specific Aim 2, we will estimate the effect of donor KIR2DL1 polymorphism on the outcome of HCTs in the context of this clinical trial. The primary hypothesis is that HCT using a KIR2DL1-R245 donor will result in a better survival rate at 1 year than those using a KIR2DL1-C245 graft. If successfully completed, this study will provide high-quality data essential for future improvement of transplant strategies for the large number of children without an HLA-matched donor.

Public health relevance
PUBLIC HEALTH RELEVANCE: The most common indication for allogeneic hematopoietic stem cell transplantation in children is high-risk acute leukemia, A key question remains on the best approach to the 40-50% of children who do not have matched donors available. One aim of this study will assess the disease-free survival of children receiving HLA haplotype-mismatched KIR-favorable related donor transplantation, and the other aim will estimate the effect of donor KIR2DL1 polymorphism on the outcome of HCTs in the context of this clinical trial.